Microheart muscle based discovery and development of inotropic compounds

Inotropes are compounds affecting heart contraction force, either positively or negatively. They are used to adjust
heart pumping in conditions like heart failure, hypertension, or cardiomyopathies. However, current agents have
limitations, including: common and risky side effects like arrhythmias and blood pressure changes, short duration
of use, dangerous drug interactions, and variable efficacy. There is thus an immediate demand for novel inotropic
compounds, along with their corresponding novel molecular mechanisms, to empower drug developers to
formulate the next wave of cardiac medications. Organos, Inc. is attempting to solve this difficult problem through
the development of advanced cardiac drug discovery platforms and technologies. Organos has produced a high-
throughput micro-heart muscle (μHM) system engineered from human-induced pluripotent stem cell-derived
cardiomyocytes (hiPSC-CMs). This 384 well format test system has been used to phenotypically characterize a
repurposing library of FDA or EMA approved compounds and has uncovered a number of compounds which
demonstrate previously undescribed cardiac inotropy. In this proposal, we seek to advance these candidate
compounds for potential repurposing and discovery of novel inotropy mechanisms. We propose to first validate
our screen results in a more mature engineered tissue platform, a microfluidics based cardiac microphysiological
system (MPS), and then verify these results in modern platforms which use adult human primary ventricular
myocytes. We will also use bulk RNA sequencing and primary cell phenotypic mapping to attempt to elucidate
mechanisms of action of these molecules. Final candidates will be tested in donor human tissue test systems,
and rodent in vivo models. The success of this project holds the potential to uncover novel drug mechanisms
and therapeutic targets aimed at addressing the need for pharmaceutical inotropic modulation of the heart.

Public health relevance
Narrative This proposal seeks to take identified compounds from a cardiac phenotypic screening program and advance them as potential inotropic pharmaceutical compounds. We will validate the screening results in more advanced testing, work to identify their mechanisms of action, and verify them with independent measures of cardiac inotropy. If successful, this effort will result in novel drugs and potential therapeutic targets for inotropic modulation of the heart.